CVM Vet-LIRN Veterinary Laboratory Diagnostic Program (U18)

Project Abstract
Virginia Tech Animal Laboratory Services (ViTALS) at the Virginia-Maryland College of Veterinary
Medicine (VMCVM) has been a member of the FDA CVM Vet-LIRN laboratory network since 2012. With
previous infrastructure funding, ViTALS was able to conduct staff training and expansion of the
molecular diagnostics section to comply with the American Association of Veterinary Laboratory
Diagnosticians (AAVLD) requirements for accreditation. ViTALS was granted accreditation in 2017. The
expertise of the faculty and staff along with the highly organized and well established facility have
served as an integral component of the network. ViTALS encompasses six units including anatomic
pathology, clinical pathology, clinical microbiology, molecular diagnostics, clinical immunology, and
clinical parasitology. ViTALS has experience and expertise in running GLP studies and is capable of
providing technical skill and support for ongoing surveillance or outbreak testing. In addition, ViTALS has
expertise in deep sequencing, in particular long read technologies, which have been employed for
bacterial, viral and parasitic whole genome sequencing as well as pathogen discovery with shotgun
metagenomics.

Public health relevance
Project Narrative The Vet-LIRN program adds a unique component to FDA investigations and testing programs, by directly examining veterinary diagnostic samples to facilitate early detection of animal food and drug adulteration or contamination. The previous outbreak of Salmonella infantis in humans from commercial pet food, and melamine in dog food as well as infant formula directly highlight the importance of effective screening of animal food and tissues to prevent disease in humans. Virginia Tech Animal Laboratory Services (ViTALS) is fully accredited by the AAVLD, a member of NAHLN, and has been a member of the FDA CVM Vet-LIRN community since 2012, and has experience and expertise in testing clinical samples and can provide technical skill and support for ongoing outbreak testing.